Maternal Interleukin-4 and allergic asthma in mouse offspring behavioral deficits

PROJECT SUMMARY/ABSTRACT
The state of the mother's immune system during pregnancy plays an important role in fetal
development, and disruptions in this immune balance are associated with a range of neuropsychiatric
and neurodevelopmental disorders. Epidemiological and clinical studies have revealed associations
between neurodevelopmental disorders including Autism Spectrum Disorder (ASD) and Attention Deﬁcit
Hyperactivity Disorder (ADHD) and family history of immune system dysfunction, most notably allergies
and asthma. Over the past three decades, analogous increases have been reported in both the
incidence of ASD, ADHD, and immune-related disorders, particularly immune hypersensitivities that
include allergies and asthma. Several case-control reports have noted that mothers with elevated
allergic-associated cytokines during pregnancy are at greater risk of having a child who was later
diagnosed with ASD or ADHD. These data raise the hypothesis that maternal allergic asthma (MAA)
produces neurobehavioral deﬁcits in offspring and highlight a yet undetermined link between the
maternal immune system and risk of neurodevelopmental disorders. Using a validated mouse model of
allergic asthma, we have demonstrated that offspring of MAA dams exhibit behavioral deﬁcits
characterized by decreased social interactions and increased repetitive behaviors. This proposal will
extend these ﬁndings by exploring the mechanistic contribution of the allergic asthma-associated
cytokine interleukin-4 (IL-4) in driving the link between MAA on offspring brain and behavior
development. Speciﬁcally we will [1] determine the contribution of maternal IL-4 signaling in
precipitating neurodevelomental deﬁcits, [2] characterize the safety and efﬁcacy of the allergic asthma
medication dupilumab, an IL-4 receptor antagonist, in preventing the effects of MAA on offspring
behavior, [3] examine the neuroimmunological consequences of MAA on offspring brain development,
and [4] associate changes in neuroimmune signaling with behavioral outcomes. The results of these
experiments will determine the extent to which maternal IL-4 signaling in allergic asthma contributes to
offspring neurodevelopmental deﬁcits and inform future therapeutic interventions for mitigating the
effects of maternal asthma in at-risk populations.

Public health relevance
PROJECT NARRATIVE Allergies, asthma, and other immune hypersensitivities during pregnancy are thought to contribute to the cause and severity of neurodevelopmental disorders. This project uses a mouse model of allergic asthma to determine whether maternal interleukin-4, an important immune signal in allergic responses, impacts offspring brain and behavior differences.